Integrative Bioinformatics

The Integrative Bioinformatics (IB) Support Group provides expertise in computational analysis and develops bioinformatics tools and resources to empower scientific research programs. The IB group is equipped with advanced computational infrastructure, including a collection of bioinformatics software, to support complex biological data analysis. The group has ample expertise in managing and analyzing biological data from diverse types of experiments including, but not limited to, NGS data analysis, single cell analysis, microbiome, metabolomics and proteomics data analysis. The group also implements analytical pipelines, establishes best practices, and develops bioinformatics tools to enhance and facilitate intramural research and discovery.

Collaborative Research:

The IB group provides direct and collaborative bioinformatics supports to research groups and other core facilities to facilitate our research and scientific discovery. In this reporting period, the IB group has worked with 42 research groups and 3 data-generating cores from NIEHS, and five external partners from UF, UCSC, UNC, Duke, and NIDDK. These collaborations resulted in 20 publications in which the group members were co-authors. For more details about scientific impacts of our collaborative research, please visit our PubMed collection at https://pubmed.ncbi.nlm.nih.gov/collections/61587586/?sort=pubdate.

Resource Development:

The IB group evaluates and develops resources and tools to enhance our data analysis power to meet the rapidly changing intramural scientific needs. In this reporting period, the group has established three new analytical workflows or approaches to facilitate the data analyses and developed two new SOPs (spatial transcriptomics and deconvolutional analysis) to benefit the research community. In collaboration with other research groups, the groups also developed SEMIPs for data-mining (PMID: 34899830, 2021) and participated in single cell DSFMix method development (PMID: 35192692, 2022). The completed list of our development publications could be viewed at https://pubmed.ncbi.nlm.nih.gov/collections/61694443/?sort=pubdate.

Training:

The IB group has offered tutorials and workshops for all levels of scientists within the institute, with a special focus on helping trainees (post-docs, post-bacs, students, and interns) to develop bioinformatics concepts and skill sets. The IB group has coordinated with the Biostatistics Branch and offered biannual short course series of 8 courses in which trainees were the major attendees. The IB group members have also engaged in multiple on-demand trainings for those who wish to acquire advanced skills beyond standard data analysis.